Neurological Disorders in HIV-1 Infection

ABSTRACT
There is a high incidence of neurological disorders (HAND) in middle-aged people living with HIV infection
(PLWH). To date, the molecular causes for diverse array of HAND remain poorly understood, and specific
pharmacological interventions to manage HAND remain elusive. The working hypothesis for this R21 is “that
the reactive glycolytic byproduct methylglyoxal (MG) is triggering the multitude of early-onset neurological
disorders by exerting varying actions of different cell types in the brain”. The aims are (1) define pathobiological
trajectory of early-onset neurological disorders in relation to MG, Glo-1, microvascular leakage, and inflammation
in HIV-1 infected Hu-mice with and with anti-retroviral treatment, and (2) show that lowering MG with novel, cell-
penetrant arginine-rich cyclic peptides will blunt neurological disorders in HIV-infected Hu-mice with and without
anti-retroviral treatment. Data generated from this R21 will establish for the first time a link between the elevated
levels of the glycolysis byproduct MG, microvascular leakage, impaired synaptic transmission, and neurological
disorders, in our clinically relevant HIV-1 infected Hu-mice model. Preliminary structure-activity relationship
studies will also provide novel insights into the use of arginine-rich cyclic peptides to scavenge MG and attenuate
these early-onset HAND.

Public health relevance
Relevance: Neurological disorders are prevalent in middle-aged people living with HIV infection. To date, the molecular cause(s) for these varied disorders remain poorly understood, and specific pharmacological treatment to blunt their development remain elusive. This project brings together the expertise of Drs. Keshore R. Bidasee (metabolism and vascular biology), Santhi Gorantla (humanized mice and HIV-1 infection) and Huangui Xiong (brain electrophysiology and HIV) to demonstrate that accumulation of the cytotoxic glycolysis byproduct methylglyoxal (MG) is triggering these diverse early-onset neurological disorders using the clinically relevant HIV-infected humanized mouse and show that scavenging MG using novel arginine-rich cyclic peptides that can attenuate these disorders.